COLONIC TRANSIT OF NON-DIGESTIBLE SOLIDS--IRRITABLE BOWEL SYNDROME

The intent of this study is to develop and validate a non-invasive physiologically controlled quantitative tomographic radionuclide assessment of colonic transit and to evaluate its clinical efficacy i the diagnosis and treatment of irritable bowel syndrome.